Targeted Cerebral Spinal Fluid (CSF) Drug Delivery - Enclear Precision System

Project Summary
EnClear Therapies is performing research for a National Institutes of Health NINDS Phase I/II
Small Business Innovation Research (SBIR) Parent Grant: 1R44NS135792-01 to develop a
novel CNS drug delivery system. EnClear Therapies’ device precisely controls the flow of
cerebrospinal fluid (CSF) to address the issue of overcoming the blood brain barrier (BBB) for
drug delivery. The system utilizes two access points, the lumbar thecal sac and cerebral
ventricle, and a precision pump for controlling the rate and direction of CSF flow between them.
The system is capable of controlling CSF flow precisely by utilizing our Sensor Array to
understand patients’ physiologic responses and allow the system to adjust drug infusion rate,
CSF flow rate, flow direction and to “oscillate” drug concentration over specific tissue targets
through a rapid flow reversal mechanism. The device will be used multiple types of CNS
therapies including for gene therapies, such as anti-sense oligonucleotides (ASO) for Frontal
Temporal Dementia.
EnClear Therapies is a small business who will use this supplement to hire a Hispanic male,
who is from a socially disadvantaged group as defined by the U.S. SBA. This Long-Term
employee will contribute to the completion of the parent Phase I/II SBIR award ongoing
research Aims. The immediate impact of this administrative supplement will be to increase
diversity at EnClear Therapies and in the United States Small Business workforce. The long-
term impact of this administrative supplement will be to help this particular individual hired to
contribute to the ongoing research, develop more skills, and launch a successful career as an
entrepreneurial-minded independent engineer.

Public health relevance
Project Narrative Relevance to Public Health: EnClear Therapies is performing research under a National Institutes of Health Phase ½ FastTrack Small Business Innovation Research (SBIR) Parent Grant: 1R44NS135792-01 to develop a more effective way of delivering therapeutics to the central nervous system. The EnClear system will improve the outcomes of patients with neurological disease by delivering needed therapeutics, in a precise personalized manner that overcomes the issue of poor CNS penetration. This administrative supplement will increase the diversity at EnClear and in the United States Small Business workforce by enabling EnClear Therapies to hire an MS-level engineer who is of Hispanic male descent (a socially disadvantaged person) to contribute to the parent Phase I/II SBIR award supported research. This new employee will contribute to the development and commercialization of a therapeutic device for drug delivery that will improve the quality of life by enabling better distribution of therapeutics for neurological diseases.